EFFECT OF CORTICOSTEROIDS ON OROPHARYNGEAL FLORA

We hypothesize that because of alterations in cellular and humoral immunity in patients receiving corticosteroid therapy, respiratory flora may be altered. The goal of this study is to determine: 1) if an alteration in flora occurs, 2) if the effect is dose or duration dependent, and 3) the time that it takes for resolution back to normal flora.